CT ANALYSIS OF FAMILIAL LARGE VESTIBULAR AQUEDUCT SYNDROME

The purpose of this study is to determine the mode of inheritance of the large vestibular aqueduct syndrome, a congenital inner ear malformation causing progressive sensorineural hearing loss and peripheral vestibular dysfunction.